Charting the post-antibiotic trajectory of the microbiome and resistome and elucidating the role of pet ownership

ABSTRACT
The gut microbiome plays a crucial role in health, and its disruption by antibiotics can lead to decreased
microbial diversity, loss of essential metabolic functions, and increased susceptibility to infections with
pathogens such as Clostridioides difficile. The mechanisms and factors influencing the recovery of the
microbiome from antibiotics remain inadequately understood. Notably, the potential impact of companion
animals on the human microbiome is often overlooked, even though recent evidence suggests that pets can
modulate the human microbiome and protect against colonization and recurrence of infection with C. difficile.
To investigate these dynamics, the REMBRANDT study (REcovery of the MicroBiome fRom ANtibiotics for
Dental implanTs) was initiated as a longitudinal cohort study examining microbiome disruption and recovery in
pet owners and non-pet owners receiving antibiotic prophylaxis for dental surgeries. Stool and saliva samples
are collected from participants, and if applicable, their pets, before, during, and after the antibiotic regimen,
alongside extensive meta-data. Currently, metagenomic 16S rRNA sequencing is performed on all samples,
which provides genus-level taxonomic data. Preliminary analyses appear to confirm that pet ownership can
influence the post-antibiotic trajectory of the microbiome. Here, we propose to sequence REMBRANDT
samples more deeply using shotgun metagenomic sequencing (SMS) to achieve higher-resolution taxonomic
profiling of the microbiome and its associated gene families and metabolic pathways. This enhanced
sequencing approach will allow for a comprehensive characterization of the taxonomic and functional
disruption and recovery of the microbiome and a more sensitive detection of patient and household-level
characteristics that affect recovery. Additionally, this approach will provide insight into the post-antibiotic
collection of antimicrobial resistance genes in the gut (the resistome) and the factors that govern the
acquisition and persistence of antimicrobial resistance genes within the host and their potential dissemination
to pets. Findings from this research will be used to inform public health strategies and interventions aimed at
enhancing microbiome recovery and limiting the spread of antimicrobial resistance.

Public health relevance
PROJECT NARRATIVE Understanding the variability in response of a person’s microbiome (collection of microorganisms in their intestines) to antibiotics is important for identifying ways to prevent the adverse effects of antibiotics - whether that is damage to the gastrointestinal tract of the individual patient or the development of antimicrobial resistance, which can impact the broader community. An overlooked aspect of this is the impact of pet ownership, which we are currently investigating in the REMBRANDT (REcovery of the MicroBiome fRom ANtibiotics for Dental implanTs) study. Here, we propose to conduct deeper sequencing of the samples collected in the REMBRANDT study to obtain greater insights into the post-antibiotic microbiome, better identify factors that impact the recovery of the microbiome, and more precisely assess the impact of pet ownership on this process.